The Next-Generation Developmental and Reproductive Toxicology (DART) Assay using High-Content Analysis of Genetically Diverse C. elegans Populations

1 Modern toxicology assessment of chemicals is under pressure from both scientific and social sources. Traditional
2 study models using small numbers of highly inbred mammals fail to reflect the wide genetic, geographic, and
3 demographic variation underlying differing population-specific responses to environmental toxicants and drugs.
4 Secondly, long-standing public pressure to reduce the use of animals in safety testing has resulted in regulatory
5 directives to ban the use of animal studies in approvals of new chemical entities and existing chemical product
6 re-registrations by 2035. This pressure along with continual advances in life science technology has led to the
7 development of new approach methods (NAMs) including in vitro, ethical in vivo, and in silico methods.
8 Environmental justice, especially for vulnerable fence line communities at much greater risk of environmental
9 exposure to chemicals, highlights the need to include vulnerable populations in toxicology studies. Modeling
10 population variation in toxic responses at the necessary throughputs is not feasible using outbred in vivo
11 mammalian models, and in vitro methods are unsuitable for assays requiring complete organisms such as
12 developmental and reproductive toxicity (DART). Using its novel vivoChip device, vivoVerse proposes a NAM
13 for DART testing based on the microscopic, soil-dwelling nematode, Caenorhabditis elegans. C. elegans has a
14 simple culturing protocol, ability to produce 300 progenies per adult, conserved toxicology pathways with
15 humans, intact germline with tractable in utero embryogenesis, is a non-sentient invertebrate with a 3-day life
16 cycle that is not subject to animal welfare legislation, and has well-characterized panels of several hundred
17 naturally occurring strains with diverse genetic backgrounds, making it a highly suitable small animal model for
18 DART assays. The vivoChip is a microfluidic-based imaging platform uniquely facilitating high-throughput
19 toxicology assays with C. elegans, using high-resolution imaging to quantify relevant phenotypic endpoints in
20 ~1,000 animals per chip. In Aim 1, we will develop a new vivoChip specifically for DART testing that allows rapid
21 immobilization of ~1,500 C. elegans of widely varying sizes. We will establish an AI/ML-assisted pipeline for
22 automated analysis of high-resolution, on-chip images of in utero, body, and organ phenotypes relevant to DART.
23 In Aim 2, we will develop a GLP-qualified DART assay that surveys 12 genetically diverse strains and
24 demonstrate strain and age-specific sensitivity for two reference chemicals. In Aim 3, we will compare DART
25 assessments with our panel of 12 strains and two sensitized mutants, with published data for chemicals of
26 significance to stakeholders, to demonstrate the value of our assay. With a more sensitive DART assay using
27 high-content readouts of in utero effects from twelve genetically diverse backgrounds, we expect to improve the
28 known safety prediction accuracies of C. elegans when compared to higher mammalian models. Armed with
29 such data, we will present our case study to the regulatory agencies for formal risk analysis, and in due course,
30 full acceptance of C. elegans as an alternative animal model for DART, making an impact on many industries.

Public health relevance
Product safety profiling, of which developmental and reproductive toxicology (DART) testing is an important component, is necessary to determine and continually ensure safe dosage or exposure levels of every chemical that comes into contact with humans. Toxicity testing is mostly done in genetically inbred mammals such as rats and rabbits, but public and regulatory pressure has led to directives eliminating the use of animals in safety testing where possible. In this proposal, we will develop a DART assay using genetically different wild strains of a microscopic soil worm, C. elegans, to provide a faster, cheaper, and more ethical alternative to testing on mammals, and investigate population-wide differences in responses to hazardous chemicals.